Patient-Oriented Research in Skin Diseases

DESCRIPTION (provided by applicant): This application proposes a renewal of a Midcareer Investigator Award in Patient-Oriented Research for Mary-Margaret Chren, MD, Professor of Dermatology at the University of California, San Francisco (UCSF). Dr. Chren's long-term career objectives are to perform rigorous research to improve the health of patients with skin diseases, and to use her research to develop first-rate investigators in patient-oriented research in skin diseases. This renewed award will build on her previous work and accomplish her immediate career objectives: first, to expand and complete the next phase of the Nonmelanoma Skin Cancer (NMSC) Cohort Study, a 10-year comparative effectiveness study of treatments for NMSC (the most common malignancy); second, to build on these findings to develop and perform a targeted multicenter clinical trial of treatments for NMSC; third, to use these research data as a substrate for the mentoring of clinician investigators in patient-oriented research; and fourth, to increase the scope of her mentoring activity by serving an expanded leadership role with the Mentorship Development Program of the UCSF Clinical & Translational Science Institute (CTSI). The proposed research will fill a gap in current knowledge about the comparative efficacy of the two most common treatments for NMSC, surgical excision and histologically-guided serial excision, or Mohs surgery. The research will undertake the incremental developmental steps to design and conduct a multicenter randomized controlled trial of excision and Mohs surgery for primary facial basal cell carcinomas (BCC). These steps include establishment of research, clinical, and stakeholder advisory groups, composition of study tools, drafting of study procedures, and pilot-testing of procedures. After infrastructure development, 1200 patients with primary facial BCC will be randomized to surgical excision or Mohs surgery. The primary outcome is tumor recurrence at five years; secondary outcome is skin-related quality of life. The proposed mentoring plan has three parts: didactic curricula, hands-on research, and career development; with the renewed award, didactic options will be fully integrated with CTSI's comprehensive program of highly-directed courses. This enhanced integration will be fostered by Dr. Chren's role as leader of the Mentor Evaluation Plan for the CTSI's Mentorship Development Program. Together, the Research Plan and Mentoring Plan provide a new five-year strategy that is directly relevant to the NIH and NIAMS missions of pursuing and applying knowledge to reduce disease burden, and training scientists to carry out such research.

Public health relevance
Project Narrative This application proposes renewal of an award to support a mentoring program in patient-oriented research in skin diseases, using an expanded research program on improving care for nonmelanoma skin cancer. The proposal is relevant to the public health because it focuses on ensuring that sufficient numbers of highly-trained and well- mentored scientists are available to perform top-quality research on health care and how to improve it. In addition, rigorous studies are needed to compare different treatments for nonmelanoma skin cancer, which is the most common malignancy; the work proposed in this application addresses that public health need. __SpecificAimsTextDelimiter__ RESEARCH PLAN 10. Specific Aims This portion of the application is organized according to the PHS 398 CDA Supplemental Form but also follows the instructions in the Program Announcement (PA-09-037) for K24 awards which stipulates that each portion of the Research Plan should be presented in two separate parts: (1) Currently supported research, and (2) New research specifically to be supported by this grant. The percent of my effort committed to the research plan for my current K24 award is 25%, which I propose to continue during a renewed award [I would devote the additional 25% effort supported by the award to the Mentoring Plan (6.)]. My objectives for my research career are contained in 3. Career Goals and Objectives. CURRENTLY-SUPPORTED RESEARCH Nonmelanoma skin cancer (NMSC) is the most frequent malignancy, with an incidence exceeding that of all noncutaneous malignancies combined 40. Further, care for NMSC is the fifth most costly of all cancers to treat for Medicare 41, indicating that determining the optimal treatment for NMSC is important to the health care system. The conventional goal of NMSC therapy is destruction of the primary cancer and prevention of recurrence; as with other non-fatal cancers, quality of life is an additional important outcome. The most common treatments are local tumor destruction (which is relatively simple and requires few resources), simple excision, and histologically-guided serial excision (Mohs surgery, or Mohs, which is highly specialized and technologically intensive). Comprehensive outcomes of different treatments have not been compared, although therapies vary significantly in cost. Our current research builds directly on our previous work in which we learned that excision and Mohs surgery, which are used differently in different practice settings 2 are nonetheless similar in short-term quality-of-life outcomes 18. Our immediate goal is to compare longer-term outcomes, including tumor recurrence, after different therapies for NMSC. We have the following specific aims and hypotheses: PRIMARY SPECIFIC AIM. To compare recurrence rates at five years after different therapies for nonmelanoma skin cancer. Primary At five years after therapy, tumors treated with tumor destruction will recur Hypothesis 1.1 more frequently than those treated with excision or Mohs surgery. Based on previous work, we expect the findings to support this hypothesis. Primary At five years after therapy, tumors treated with excision or Mohs surgery Hypothesis 1.2 will have similar recurrence rates. Based on previous work, we expect the findings to support this hypothesis. ADDITIONAL SPECIFIC AIM. To compare skin-related quality of life at five years after different therapies for nonmelanoma skin cancer. Additional At five years after therapy, patients treated with tumor destruction will Hypothesis 2.1 experience less improvement in skin-related quality of life than patients treated with excision or Mohs surgery. Based on our previous work, we expect the findings to support this hypothesis. Additional At five years after therapy, patients treated with excision or Mohs surgery Hypothesis 2.2 will experience similar improvements in skin-related quality of life. Based on our previous work, we expect the findings to support this hypothesis. NEW RESEARCH SPECIFICALLY TO BE SUPPORTED BY THIS GRANT Overall direction of new research. If this application for a renewed K24 award is funded, I will build directly on our previous work and will pursue two additional research objectives (Figure 3. Framework for career goal and objectives): First, we propose to expand the findings of the NMSC Cohort Study, e.g., to determine in detail predictors of tumor recurrence, and to learn the clinical course of important subgroups such as the old-old and patient with complex comorbidities. Second, I will develop and perform a targeted randomized controlled trial of therapies for basal cell carcinoma. This incremental research strategy is compelling given (1) our initial results showing wide unexplained variations in care for NMSC 2, (2) our finding that two common therapies for NMSC, excision and Mohs surgery (which vary in usage and cost), have similar short-term quality-of-life outcomes 18, and (3) recent data from an RCT in Europe suggesting that there is no significant difference in recurrence of facial primary basal cell carcinoma after excision or Mohs 42. In describing new research for this proposal, I will focus on this plan to develop and perform a large RCT. For this new research, we have the following specific aims and hypotheses: PRIMARY SPECIFIC AIM. To assess whether surgical excision or Mohs sugery is superior in preventing five-year recurrence of primary facial basal cell carcinomas. Primary At five years after therapy, tumors treated with excision or Mohs surgery will Hypothesis have similar recurrence rates. Based on our previous work, we expect the findings to support this hypothesis. ADDITIONAL SPECIFIC AIM. To assess whether surgical excision or Mohs surgery is superior in improving five-year quality-of-life outcomes of primary facial basal cell carcinomas. Additional At five years after therapy, patients treated with excision or Mohs surgery will Hypothesis experience similar improvements in skin-related quality of life. Based on our previous work, we expect the findings to support this hypothesis.